Molecular Regulation of a Transcriptionally Poised State in Neurons and its Role in Learning

PROJECT SUMMARY/ABSTRACT
Rapid and transient induction of gene expression in neurons is necessary for memory formation. Genes
that are activated in the brain in response to stimuli are regulated by the release of a poised transcriptional
state, where RNA polymerase II (RNAP2) pauses just downstream of the gene promoter after initiating
transcription. When calcium-dependent signaling cascades are triggered, the RNAP2 pause is released. This
release allows RNAP2 to elongate across the length of the gene, and messenger RNA (mRNA) transcripts are
generated. There is a transcriptional refractory period that lasts for hours after a stimulus when neurons are
transcriptionally unresponsive to subsequent stimuli that may be linked to the time it takes to reset poised
RNAP2. This period of dampened transcriptional response may explain the phenomenon where animals that
have little time between training sessions do not learn as well as animals with more spaced out training
session schedules, despite total training time being equal between groups. Preliminary experiments point to
Hexamethylene bisacetamide inducible protein 1 (HEXIM1) as a critical factor for setting up and resetting the
poised state in neurons due to its ability to sequester the positive transcription elongation factor b (P-TEFb)
protein complex, which is responsible for releasing the RNAP2 transcriptional pause. While other regulators of
P-TEFb have been linked to human cognitive diseases including intellectual disability, Alzheimer’s, mood
disorders, and others, very little is known about HEXIM1 in the brain.
The central hypothesis of this project is that suppression of P-TEFb by HEXIM1 in neurons is required for
RNAP2 to set up a poised state so a burst of gene expression can be induced in response to a stimulus, and
that while the poised state is getting set up following a transcriptional burst, learning is impaired. I will test this
hypothesis with three specific aims. Aim 1 will explore the regulation of the P-TEFb/HEXIM1 complex by
calcium channels to identify which memory-associated calcium signaling pathways impact P-TEFb activity.
Molecular associations between P-TEFb and HEXIM1, and their dependence on calcium-associated
phosphorylation events will be tested using biochemical assays in primary neuron cultures. Aim 2 will test how
RNAP2 cycles through a set of steps (poise, elongate, disengage, then poise again) that dictate levels of gene
inducibility following neuronal depolarization. Confocal microscopy, immunocytochemistry, and florescence in
situ hybridization will be combined to ascertain the association of inducible genes with nuclear
subcompartments in containing poised, elongating, and inactive RNAP2 during and after neuronal stimulation.
Aim 3 will probe the role of HEXIM1 in memory and determining the rate of learning. Behavioral tests will be
conducted in mice after knockdown or overexpression of the Hexim1 gene in the hippocampus. This career
development award will further develop the translation of my skillsets in studying transcriptional regulation
mechanisms to the study of learning and memory.

Public health relevance
PROJECT NARRATIVE The formation of a new memory requires a rapid increase in the synthesis of messenger RNAs via the process of gene transcription in the brain, and many of the molecular processes underlying gene transcription regulation are disrupted in cognitive disorders. Rapidly inducible gene transcription requires a set of factors that regulate a poised, ready for activation, state within the nucleus, but how this poise is established has not been investigated in neurons. This project will examine the molecular players that regulate the poised state before, during, and after neuronal stimulation to understand whether they influence the capacity of the brain to form memories.